Stress and Cardiovascular Risk Among Urban African American Adults: A Multilevel, Mixed Methods Approach:Supplement

PROJECT SUMMARY/ABSTRACT
The proposed study will utilize two waves of data from the parent study titled "Stress and Cardiovascular Risk
Among Urban African American Adults: A Multilevel, Mixed Methods Approach" (R01 HL153377-01A1), led by
Dr. Samuele Zilioli. This parent study aims to identify pathways linking psychosocial stressors to cardiovascular
risk among middle-aged and older African Americans. Our study will include 526 asymptomatic African
Americans, aged 55-77, residing in metro Detroit. Aligned with the broad overarching goals of the parent study
of exploring the relationship between social ecology and cardiovascular risk in midlife and older age, we will
investigate the prospective associations between religiosity and inflammation. Our theoretical model proposes
that religion can influence cardiovascular disease through three mediating pathways: psychological, social, and
behavioral. To date, no study has collectively tested these pathways among middle-aged and older African
American adults. Using multiple latent change score modeling, we hypothesize that greater religious
attendance will be associated with more positive religious coping, higher perceived social support, and lower
alcohol usage, which in turn will be associated with lower inflammation levels (i.e., basal and stimulated
cytokines). Understanding these mediating pathways could inform culturally tailored interventions that harness
the protective effects of religion as a social determinant of cardiovascular health for African American adults.

Public health relevance
PROJECT NARRATIVE The proposed project aims to test multiple biopsychosocial pathways that link religious attendance to systemic inflammation among middle-aged and older African American adults. The results can provide valuable insights into the mechanisms connecting religiosity to healthy aging in this population. The knowledge gained from this project will be instrumental in developing tailored interventions to reduce cardiovascular disease risk among African Americans and potentially other racially minoritized groups.